Cincinnati Training Program in Pediatric Rheumatology

This T32 application for the Research Training Program (RTP) for Pediatric Rheumatic Diseases seeks to equip
pediatric rheumatology fellows with the investigative skills necessary to succeed in meaningful scientific careers
in academic pediatric rheumatology. The program is based in a large Division of Pediatric Rheumatology (PR)
with two P30 center grants and several NIH-funded investigators. The Pediatric Rheumatology Division, including
its related clinic, is part of Cincinnati Children’s Hospital Medical Center (CCHMC) and The Cincinnati Children’s
Research Foundation (CCRF), as well as part of the University of Cincinnati College of Medicine (UCCOM) with
its clinical and biomedical science departments. The Pediatric Rheumatology divisional research program draws
strength from uniquely integrated teams of clinical, translational, and basic researchers involved in active
ongoing collaborations with members of Divisions of Immunobiology, Human Genetics, Hematology/Oncology,
Bone Marrow Transplantation, Nephrology, Radiology, Psychology and Bioinformatics. The primary faculty
advisors have been selected from 12 specialties divisions based on the ongoing collaboration with Rheumatology
faculty, high research productivity and strong record of training of young scientists. In parallel to the two focus
areas of divisional research, this T32 RTP has been offering two distinct research career pathways or training
tracks. Trainees deciding to pursue laboratory based basic and translational research careers follow the
Laboratory Research Track. Although most trainees in this track have been MD or MD/PhD, it also attracts
PhD scholars who would like to apply their knowledge to address questions relevant to PR. The focus areas of
the training in this track include basic disease biology and functional genomics in PRDs. Trainees deciding to
pursue clinical research careers follow the Clinical Science Track. This track encompasses didactic and hands-
on training in study design, biostatistics, research methods, clinical epidemiology, and outcome measure
development. The program is well supported by core facilities as well as by academic courses, including a
mandatory course in medical ethics and responsible conduct of research. Other available courses include
computational system biology, immunobiology, molecular genetics, epidemiology, and biostatistics. The
interdepartmental Immunobiology Graduate Program (MS and PhD) that is centered at CCHMC complements
existing programs in Epidemiology and Biostatistics, and Education in the UCCOM. It is believed that this RTP
provides unique resources and will continue to enlarge the pool of individuals with a career interest in biomedical
science as it relates to pediatric rheumatology, a pool that is far too small to meet the requirements of the next
decades as molecular medicine is increasingly applied in the clinic.

Public health relevance
PROJECT NARRATIVE This Research Training Program based in a large Division of Pediatric Rheumatology (PR) with several NIH center grants and NIH-funded investigators seeks to equip PR fellows with the investigative skills necessary to succeed in research careers. The research training activities will have two focus areas: (1) Laboratory Research Track, with application of genomics, epigenetics, proteomics, and metabolomics to advance PR translational research, and (2) Clinical Science Trac, with clinical epidemiology, development of clinical outcome assessment tool and clinical trial design. It is expected that this program will enlarge the number of PR researchers, a pool that is far too small to meet the requirements of the next decades as molecular medicine is increasingly applied in the clinic.